Collagen Signaling in Pancreatic Cancer

Abstract
Pancreatic Ductal Adenocarcinoma (PDA) is the 3rd most common cause of cancer death in the United
States. One of the primary pathological features of PDA is the dense network of fibrillar collagens
(COLs), including COL1 and COL11, both of which have been shown to be associated with PDA
progression. Collagens signal via specific receptors on the surface of PDA cells, of which the Discoidin
Domain Receptor 1 (DDR1) is a unique collagen receptor tyrosine kinase (RTK). We have found that
ablation of DDR1 inhibits disease progression and metastasis whereas overexpression enhances these
processes in mouse models of PDA, suggesting that DDR1 is a major promoter of malignancy. The
signaling networks activated by DDR in response to COLs remain elusive. Using an innovative
approach to simultaneously map the phospho-catalytic profile of multiple kinases in cells or tissues we
discovered that tumor xenografts of PDA cells expressing DDR1 embedded within in a COL1 scaffold
display a unique profile of activated kinases, which represent new DDR1-initiated signaling pathways
revealing potentially druggable vulnerabilities to target these highly fibrotic tumors. We have also found
that COL5 and COL11, fibrillar collagens associated with poor outcome in PDA, actives DDR1 to an
almost 20-fold greater level that COL1, its most commonly examine ligand. In this proposal, we will
focus on how 1) the COL11/DDR1 signaling axis promotes PDA metastasis in vitro and in vivo 2) how
distinct COLs differentially activate DDR1 3) identify druggable vulnerabilities associated with COL5/11-
DDR1 signaling to develop for future treatments of these highly fibrotic tumors.

Public health relevance
Narrative Collagens are a major component of the pancreatic cancer microenvironment, which has been implicated in the regulation of tumor malignancy. Our research focuses on understanding the function of a unique collagen receptor, known as DDR1 (Discoidin Domain Receptor 1), that transmits collagen signals in pancreatic cancer cells, mediating metastatic progression. Our studies deploy a synergistic team of experts focused on dissecting the roles of collagen-stimulated DDR1 in pancreatic cancer signaling and metastasis, with the future goal of targeting this signaling axis for improving pancreatic cancer patient survival.